Pairing tVNS with motor skill training in older adults

Summary
Motor function is often compromised by neurological injury, such as stroke and even healthy aging. Decline in
motor skills reduces the quality of life and independence in aging adults. In animal studies, applying brief vagus
nerve stimulation (VNS) during motor training dramatically improved motor recovery and learning (180-260%),
including strength and motor skills in stroke, spinal cord injury, and nondisabled rodents, young and old. Because
VNS upregulates central neurotransmitters linked with motor learning (e.g., norepinephrine, acetylcholine), which
decrease with age, this intervention is a hopeful candidate to help improve motor function in aging humans. This
project will explore the crucial unresolved issues in translating the animal-based VNS intervention to human
applications. One is the need to apply stimulation only after a successful trial to induce positive efficacy (post-
success VNS), according to systematic studies in animal research. The second issue is the invasive procedure
of implanting a VNS electrode and device in the neck and chest of humans, which would not be readily
acceptable for study or rehabilitation purposes. The efficacy of adopting a noninvasive alternative,
transcutaneous VNS (tVNS) via surface electrodes on the tragus of the outer ear, will need to be explored. To
explore these critical issues, we have published a paper confirming that applying tVNS during training alters
motor adaptation in young adults and have developed a closed-loop, automated, post-success tVNS system in
which an individual’s motor performance is assessed in real time, and tVNS is automatically applied after a
successful trial based on predetermined criteria. In this project, our primary aim is to examine the effect of post-
success tVNS during motor training on motor learning in healthy older adults. We will also explore whether the
amount of expected motor learning facilitation is associated with acute neuromodulation responsiveness to tVNS
at rest. We will randomly assign healthy older adults to the tVNS or control group. Participants will undergo motor
skill training sessions with post-success tVNS or sham stimulation, respectively. We will compare the time course
of improvements and transfer of motor skills between the groups. We will also investigate the correlation between
the improvements and a biomarker of acute neuromodulation response to tVNS (i.e., pupil size). This study will
furnish vital information on the efficacy of post-success tVNS in enhancing motor learning for healthy older adults,
and it has the potential applicability to other tasks, including whole-body control and strength, making it clinically
significant. Future clinical studies can determine if this intervention is beneficial in treating individuals with
movement disorders that suffer from spasticity (e.g., stroke, spinal cord injury), dyskinesia (Parkinson’s Disease),
tremor (e.g., Essential Tremor), and discoordination (e.g., Spinocerebellar ataxia).

Public health relevance
Narrative Motor function is often compromised as part of the normal healthy aging process or due to acute neurological insult, such as stroke and spinal cord injury. This project is expected to demonstrate that when the sensory afferent vagus nerve is stimulated noninvasively during motor training, motor skill improvement is enhanced in healthy older adults. The expected findings will be the foundation for opening new research directions, tool development, and applications to rehabilitation for various populations with movement disorders.